XENOBIOTIC-INDUCED ADAPTIVE LIVER GROWTH

Using mirex, an organochlorine compound, it is possible to initiate an adaptive liver growth response which is either hyperplastic or hypertrophic. That is, hyperplastic liver growth is induced in mirex-dosed adrenalectomized rats and hypertrophic liver growth is induced in mirex-dosed thyroidectomized rats. Previous studies have shown that the mirex-induced hypertrophic growth response is corticosterone dependent and the mirex-induced hyperplastic growth response is corticosterone independent. The objective of the proposed research is to investigate the role of corticosterone in mediating mirex-induced adaptive liver growth. To accomplish this, studies are proposed to investigate: transport/delivery of corticosterone to the liver by analyses of free and bound plasma corticosterone and corticosteroid-binding globulin; the unidirectional influx of corticosterone into the liver; hepatic cytosolic glucocorticoid receptor binding and characterization of hepatic binding proteins as the initial step in corticosterone's control of liver growth; and, hepatic tyrosine aminotransferase induction as a measure of the liver's responsiveness to corticosterone during mirex-induced liver growth. Mirex-induced adaptive liver growth provides an in vivo model to: establish the basic sequence of events involved in initiation of cellular hypertrophy, and/or hyperplasia; provide an understanding of the mechanism of induction of these two basic cellular responses; and, give insight into the mechanism of chemically- induced tumor growth. The proposed studies will also provide a means to characterize the role of the endocrine system in controlling chemically-induced stress responses at the cellular level.